Psychosocial Core

ABSTRACT- PSYCHOSOCIAL CORE
The NYU-ADC has pioneered in the development of comprehensive counseling for family caregivers of people with
AD, and has established a national reputation in this field. The Psychosocial Core will provide resources, including
data and participants, for the design and evaluation of new psychosocial interventions for all older adults who
participate in the NYU-ADRC, including those with early signs of cognitive impairment, and continue to support
its nationally known caregiver intervention research program. The affiliated Psychosocial Research Program
continues to develop and evaluate innovative projects to reduce the emotional consequences of cognitive
decline. New since 2016 is the affiliated Family Support Program, which serves caregivers throughout NYC.
Expanded research on supportive interventions will continue in the upcoming period. The Psychosocial Core will
continue to conduct comprehensive psychosocial assessments and to provide counseling and support to
participants in the ADRC and to the family members of participants with MCI and early dementia. The counselors
will maintain contact with family caregivers of participants with moderate to severe AD, after they are no longer
receiving in-person annual assessments, to increase the likelihood of autopsy of these participants. These
activities of the Core enhance the ability of the ADRC to retain its clinical population through autopsy. The
Psychosocial Core interacts closely with the other Cores and provides valuable support to the research projects,
clinical trials and pilot studies associated with the ADRC and with collaborating investigators. The Psychosocial
Core conducts a Psychosocial Assessment of all participants with normal cognitive function and MCI, and of
study partners of those with MCI and caregivers of participants in the early stage of dementia. The assessment
now includes measures to enable research about the relationships between psychosocial and cognitive changes
associated with aging and incipient dementia, and investigate causes for disparities between impairment in day-
to-day function and results of cognitive tests and brain imaging evaluations. The Psychosocial Core data,
together with the other data in the ADRC database, will provide a uniquely comprehensive dataset to inform the
design of innovative psychosocial interventions for older adults with age-associated cognitive changes and MCI.
Psychosocial data on individuals with normal cognitive function and MCI, and on the family members of people
with MCI and AD, can be integrated with information from the Clinical, Neuroimaging, Biomarker and
Neuropathology Core evaluations and become the basis for new studies in the affiliated Psychosocial Research
Program. The Core will continue to provide clinical and research training and mentor new investigators. The
breadth of research on psychosocial interventions is a defining attribute of the NYU-ADRC, and the Psychosocial
Core will continue to provide resources for research to understand and mitigate the psychosocial impact of memory
loss associated with both normal aging and disease.